Pathways of Personality Disorder: Combining Multiple Methods of Repeated Assessment Across Development and in Daily Life

PROJECT SUMMARY
Personality disorder (PD) is a severely debilitating psychiatric illness. PD is associated with high healthcare
costs, high rates of self-harm and suicidality, and greater disability than major depressive disorder. PD
demonstrates a comparable or higher prevalence to depressive and anxiety disorders, and a comparable
prevalence to physical conditions such as back pain and respiratory illness; yet, research on the
developmental pathways of PD is scarce compared to that of other mental disorders, despite clear evidence for
the onset of PD during adolescence. Moreover, a need has been identified to shift from static to dynamic
models of psychopathology that focus on core underlying processes in order to innovate methods of detection,
prevention, and intervention. The current study draws on recent advancements that identifies a single
underling severity continuum of personality pathology, that is, maladaptive self and interpersonal functioning,
as defined in the DSM-5 Alternative Model for Personality Disorders, and referred to as the Level of Personality
Functioning (LPF). The LPF consists of identity, self-direction, empathy and intimacy – core developmental
processes that emerge in adult form during adolescence, thereby allowing the empirical inquiry into the
developmental trajectories of PD. Against this background, the current project leverages over 17 years (N =
348) of previously collected longitudinal data from the Preschool Depression Study (5R01MH090786-12) to
investigate the prediction of daily LPF from developmental trajectories of emotion dysregulation, self-
dysfunction and interpersonal dysfunction by combining this data with proposed new data collection of daily
LPF using ecological momentary assessment (EMA). By combing these two forms of rich, repeated
assessment, we will examine how core processes of PD unfold at the macro-level (across development) and
manifest in emerging adulthood at the micro-level (in daily life with newly-collected EMA data). Aim 1 will
identify associations between developmental trajectories of emotion dysregulation, self- and interpersonal
dysfunction, and daily levels of LPF. It is hypothesized that increasing levels of emotion dysregulation,
interpersonal dysfunction, and self-dysfunction across development will predict more pathological daily LPF.
Aim 2 will elucidate the relative predictive power and interactions among emotion dysregulation, interpersonal
dysfunction, and self-dysfunction in predicting adult daily LPF. It is hypothesized that disturbances in identity
and self-function will interact with emotion dysregulation and interpersonal dysfunction to predict greater daily
LPF, and that increases in self-dysfunction from adolescence to emerging adulthood will be the strongest
predictor of daily LPF, as compared to trajectories of emotion dysregulation and interpersonal dysfunction.
Together, this work will reveal dynamics and nuances in the development and daily functioning of personality
disorder, aiding methods of targeted early intervention and prevention.

Public health relevance
PROJECT NARRATIVE Despite the extreme impairments and high economic costs caused by personality disorder (PD), there is a dearth of research that has investigated the developmental pathways of PD and how they may relate to current daily functioning. The current study leverages over 17 years of previously collected longitudinal data from the Preschool Depression Study (PDS) to evaluate how and when core personality processes unfold across development to predict daily levels of personality functioning in now emerging adults (new data collection using ecological momentary assessment). Results will elucidate the developmental unfolding and daily manifestation of core personality processes at the within- and between-person level in young people, thereby allowing for the identification of targeted early intervention and prevention of PD.